Dysregulation of Gamma Secretase in Common Acquired Hidradenitis Suppurativa

Project Summary
Hidradenitis suppurativa (HS) is a chronic inflammatory disease that significantly reduces quality of life due to
debilitating skin lesions and scarring. HS may be caused by a single gene mutation, most commonly in the
nicastrin (NCSTN) subunit of the γ-secretase (γS) protease complex, which regulates substrate access to γS.
In a majority of patients with acquired HS, there is no identifiable mutation, yet they suffer an identical clinical
phenotype to monogenic HS. While HS has historically been understood as a disease of keratinocytes, recent
discoveries have identified dermal fibroblasts as important loci of inflammatory signaling in HS skin. Further,
NCSTN is decreased in dermal fibroblasts of acquired HS patients, which may drive aberrant immune signaling
from these cells. These findings support the global hypothesis that acquired HS phenocopies monogenic HS
due to shared loss of NCSTN and subsequent γS dysregulation. However, the enzymatic activity of γS in HS
patients, as well as the factors which drive NCSTN loss, remain exciting areas of future discovery.
Epidemiological studies suggest that cases of acquired HS have been increasing over the past 3 decades.
Given well-characterized clinical data that HS only occurs post-puberty and improves with hormone-modifying
medications, this increase is likely to be driven in part by an environmental factor. Additional data suggests that
in acquired HS, both skin lesions and fibroblasts cultured ex vivo have high levels of plastic-associated
endocrine disruptors (pEDs) compared to healthy controls and that NCSTN protein expression in fibroblasts is
decreased by exposure to physiologically relevant concentrations of pEDs.
To address these questions, I plan to define the enzymatic activity of γS and regulation of NCSTN expression
in HS fibroblasts and in pED exposure. My preliminary analysis indicates that γS proteolytic activity is
decreased in HS fibroblasts for a specific substrate, which may drive downstream inflammatory pathways. In
this project, I will test the hypothesis that that γS kinetics and NCSTN regulation in HS fibroblasts differ from
healthy controls and that treatment of normal fibroblasts with pEDs will phenocopy HS. I will quantify γS activity
using a Förster resonance energy transfer (FRET) assay and characterize changes in inflammatory cytokines
using functional in vitro studies. In parallel, I will also characterize the regulation of NCSTN protein expression
and identify major regulatory networks in HS and pED exposure by analyzing chromatin accessibility and gene
expression through single-cell ATAC and RNA sequencing.
With these studies, I hope to define the role of γS activity and NCSTN regulation in HS. Further, I aim to
definitively clarify the role of pEDs in HS through rigorous studies. Understanding these relationships could
have important implications for the treatment and management of HS and other diseases with γS dysfunction.

Public health relevance
Project Narrative Hidradenitis suppurativa (HS) is a chronic inflammatory skin disease that, for a small number of patients, is caused by a mutation in the nicastrin protein, which is a part of the gamma secretase complex responsible for cleaving many cellular substrates. Recent studies show that, for HS patients without a specific mutation, their dermal fibroblasts still have lower nicastrin levels; I have observed that these patients may also have altered gamma secretase activity, as well as higher levels of plastic-associated endocrine disruptor chemicals (pEDs) that may reduce gamma secretase activity. This project aims to test whether gamma secretase activity and nicastrin regulation differ in HS patients and if pED exposure can recapitulate these differences in healthy cells, potentially improving HS treatment and our understanding of pED impacts on health.